Interdisciplinary Research Training in Pain and/or Substance Use Disorders

Project Summary/Abstract:
This competing application seeks an additional five years (Years 11-15) of support for a postdoctoral research
training program in pain and substance use disorders (SUDs). The magnitude of these two problems in the
United States is astounding. Over 100 million Americans have pain that persists for weeks to years, and over
20 million meet the diagnostic criteria for a SUD, costing our country over $1 trillion annually. Contemporary
neurobiological, psychological, and epidemiologic research, as well as the tragic experience of the opioid
addiction epidemic show a clear intersection of pain and SUDs. Two of the National Academy of Medicine
Relieving Pain in America committee’s recommendations for improving research at a national level are to (1)
increase support for interdisciplinary research in pain and (2) increase the training of pain researchers.
Similarly, the NIH Helping to End Addiction Long-term Initiative has called for increased training of
multidisciplinary researchers in SUDs, pain, and their intersection.
Our proposal describes a collaborative, interdisciplinary postdoctoral (PhD, MD/PhD, and MD) training program
that will produce diverse scientists with a rigorous grounding in pain and SUD research. We request support for
10 postdoctoral fellows. The fellowship typically lasts 2 years for PhDs and 3 years for MDs seeking a robust
research foundation. The 23 accomplished faculty mentors are committed to interdisciplinary collaboration and
team-based mentorship across their substantive areas of expertise, which range from cells to society. Specific
faculty expertise and training opportunities include molecular and cellular biology, optogenetics,
electrophysiology, genetics, cognitive neurosciences, psychology, neuroimaging, data sciences, epidemiology,
health policy, and economics of pain and SUDs.
The training program, housed in the Division of Pain Medicine, Department of Anesthesiology, Stanford
University School of Medicine, develops postdoctoral trainees’ skills to prepare them to become independent
investigators in the fields of pain and SUDs. The training program includes required and elective coursework,
mentored research experiences, an individual integrated research project, seminars, and professional
development, including grant and manuscript writing. The training program will continue to be led by Sean
Mackey, MD, PhD, in collaboration with a steering committee comprising senior scientists/mentors and a
faculty leader in diversity, equity, and inclusion. This team will oversee the program's recruitment, training,
scientific, and administrative aspects, including a rigorous internal and external evaluation process. In
summary, this training program will bring together a diverse and talented group of postdoctoral trainees, an
accomplished team of interdisciplinary mentors, an effective administrative structure, and a world-class
research environment at Stanford University. The combination of talent and environment will launch the next
generation of independent investigators dedicated to pain and SUD discovery research and clinical translation.

Public health relevance
Project Narrative: Pain and substance use disorders (SUDs) are highly prevalent, commonly co-occurring and confer a tremendous toll on society. There is an urgent need to train interdisciplinary researchers who can better characterize these important conditions and translate discoveries to safe and effective treatments. The aim of this postdoctoral training program is to develop the next generation of scientific leaders in pain and SUDs.